Understanding and targeting mutant splicing factors in pancreatic cancer

Pancreatic ductal adenocarcinoma (PDAC) is a highly aggressive and lethal cancer that is resistant to
currently available therapies. Notably, we discovered that PDACs are exquisitely susceptible to a range of
therapies directed at RNA splicing. However, it is unknown how alterations in RNA splicing drive PDAC
tumorigenesis or impact therapeutic responses. Thus, identification of the role of aberrant RNA splicing in
PDAC tumorigenesis could reveal novel therapeutic targets for PDAC. Our long-term goal is to identify,
design, and test novel mechanistic-based targeted therapies for highly aggressive tumors such as PDAC. The
main objective of this proposal is to characterize the role of RNA splicing factor mutations in PDAC
pathogenesis and treatment response. Recently, we identified that the most common gain-of-function driver
mutations found in 50% of PDACs (mutant KRAS and p53) synergize and cooperate through altered RNA
splicing. While >90% of PDAC cases harbor mutant KRAS, only 50% co-occur with mutant p53. We
performed mutual exclusivity analysis among hundreds of annotated mutations in PDACs and identified two
mutant splicing factors, SF3B1 and RBM10, that co-occur with mutant KRAS but do not co-occur with mutant
p53 and are mutually exclusive between each other. Additionally, our proof-of-concept studies using newly
generated genetically engineered mouse models, oligo-therapy and RNA splicing inhibitors demonstrated that
RNA splicing is a therapeutic target. Our central hypothesis is that persistent RNA splicing defects,
downstream of SF3B1 and RBM10 mutations, are a required adaptive mechanism for KRAS-mediated
tumorigenicity and represent a therapeutic target for PDAC. We aim to 1) determine the role of aberrant RNA
splicing in PDAC tumorigenesis, 2) identify the function and correct RNA splicing defects in pancreatic
cancer, and 3) evaluate the impact of mutant RNA splicing factors on the therapeutic efficacy of spliceosome
inhibitors and chemotherapeutic agents. Our expected outcomes include identification of 1) how aberrant
RNA splicing underlies major cancer-driving events, 2) novel therapeutic targets for our newly generated
oligo-therapy or small molecule inhibitors, and 3) a previously overlooked mechanism for how cancer can
evolve through multiple mutations converging at a common mechanistic function. We will use innovative
newly generated genetically engineered mouse models co-expressing KRAS and splicing-factor mutations in
the pancreas leading to autochthonous PDAC resembling patient tumors, and we will employ novel
computational and genetic biotechnologies to identify and correct RNA splicing defects. These results will
uncover a fundamental, yet novel non-mutational mechanism required for PDAC pathogenesis: altered RNA
splicing. This will provide a strong basis for future approaches to treat PDAC, which would significantly impact
personalized therapies and patient outcomes. This research directly aligns with NCI’s mission to advance
scientific knowledge of drivers and targets of cancer to improve patient’s lives.

Public health relevance
PROJECT NARRATIVE This project is relevant to public health because identifying mutations that drive pancreatic cancer could reveal novel targets to treat this deadly and currently therapeutic-resistant disease. We recently identified a group of mutations related to RNA splicing that can be blocked with both existing and emerging therapies that impede tumor growth and extend survival in animal models. In the proposed work we will 1) determine the role of these mutations in driving pancreatic cancer development, 2) identify and correct the RNA splicing defects required for the mutations to exert their effects, and 3) test two types of novel therapies to restore normal RNA splicing and determine anti-tumor efficacy.